Biophysical Instrumentation and Methodology

The intent of this project is to develop new and improve existing instrumentation and to develop new experimental and data analysis methods for the characterization of biological macromolecules and the study of their interactions. In the area of the analysis of the data from analytical ultracentrifugation, further refinements have been made in the major breakthrough achieved by the use of light intensity data rather than light absorbency data from the analytical ultracentrifuge. The intensity data is advantageous because of its superior statistical properties and its potential to provide better parameter estimates in ultracentrifugal analyses. Extensions in this method have involved enhancing the applications of Monte Carlo methods for the estimation of the errors in the parameters obtained when fitting data by non-linear least-squares curve-fitting. Work on other statistical measures of error analysis is continuing. Additional experience with this method has been gained, as it has been extensively applied to a variety of interacting systems studied in a variety of collaborative projects.